Achieving ultra-high-density, ultra-high-precision single molecule localization microscopy with whole-video deep learning architectures

PROJECT SUMMARY/ABSTRACT
Superresolution microscopy is an incredible family of approaches that have provided easier observability of
nanometer-scale features using visible-light fluorescence which was previously limited to ~200-300 nm. The
highest resolution of these techniques is single molecule localization microscopy (SMLM), in which an otherwise
dark field has random, sparse fluorescent flashes. These flashes may be achieved either through a photophysical
process on a stationary fluorophore (STORM/PALM) or through a kinetic process where a mobile fluorophore is
transiently fixed to a target (PAINT). A point-source diffraction-limited flash can be localized with precision on the
order of 1-20 nm. However, the requirement for sparsity means that the fluorophore blinking rates need to be
carefully optimized, the acquisition time for a video can be quite long, and most localization methods scale poorly
with the number of localizations. These and other issues are challenging for routine usage of SMLM, including in
the single-molecule diagnostic assay and sequencing platform that XGenomes is developing. In this Phase I
project, XGenomes will build machine learning algorithms to analyze whole SMLM videos to identify emitter
positions at ultra-high precisions and ultra-high densities. In Aim 1, we will create the SMLM video simulator
necessary to generate training data. In Aim 2, we will build a machine learning-based grouping algorithm that can
work with existing localization data and primarily improve the speed and accuracy of analysis. In Aim 3, we will
build a machine learning model to analyze whole SMLM videos at once and pushing the density up an order of
magnitude higher than current algorithms can achieve. This work will be made freely available for use to the
academic research community. The successful completion of these aims will create a leap forward in SMLM and
will unlock new uses for theses technologies.

Public health relevance
PROJECT NARRATIVE Superresolution microscopy, particularly single-molecule localization microscopy, can reveal the nanoscopic organization of biological structures and can enable cheap, accurate, high-density diagnostic assays. Current technology often requires extended, potentially prohibitive, imaging and analysis time. XGenomes is developing machine learning-based methods to rapidly and accurately analyze this data, making superresolution microscopy more accessible.